Core--Recruitment

DESCRIPTION: Recruitment Core - under Alan Schatzberg - will help recruit both patients and healthy controls. By establishing a new site in San Francisco, it will allow for a 30-40% increase in the recruitment rate and will broaden the ethnic mix by helping to recruit Asian - and Afro-Americans to the studies.